Administrative Core

SUMMARY
The mission of this ADMIN core is to be responsible for the leadership, integration and successful
implementation of the COBRE for South Carolina Translational Research Improving Musculoskeletal Health
(SC-TRIMH). The ADMIN Core director is Hai Yao, Ph.D. with Martine LaBerge, Ph.D. as Associate Director;
Windsor Sherrill, PhD. and Michael Kern, Ph.D. complete the 4 member Executive Committee (EC). An
Internal Advisory Committee of 9 senior institutional leaders and an External Advisory Committee of 3-5
eminent scientists will provide objective oversight, evaluation and strategic interactions to optimize the Center's
impact. A Clinical Advisory Committee of 7 physicians will give insight into clinical problems that will focus
junior investigator (JI) research, plus help advance innovation and give mechanistic understanding into
translational/clinical benefits. The aims of the ADMIN Core are to: (1) Provide effective Leadership and
Management to the SC-TRIMH, (2) Enhance Mentoring and Faculty Development by establishing a rigorous
program that uses a “360° style” evaluation process to benefit both mentor and mentee, (3) Initiate a Pilot
Projects Program with the SC-TRIMH themes to attract new and/or established investigators, enabling them to
generate preliminary data via access to scientific cores, mentoring and all other programmatic resources with a
goal of obtaining extramural competitive research awards, and (4) Develop and implement an integrated, long-
term evaluation plan, with formative and summative methodologies, to assess the overall Center and its
component parts. Innovative features of this ADMIN Core include: (1) Virtual Human Trials (VHT), bridging the
gap between benchtop and clinics, via the iterative process of (i) computer simulation, (ii) device fabrication
and/or sensor implantation, (iii) combined with in vivo assessment in animal or human cadavers. (2) Utilizing
the strengths of engineering expertise, principles, and practices to achieve translational biomedical benefits.
(3) Mentoring Team: each JI will have a primary and secondary mentor and all the SC-TRIMH members will
be a resource to enhance and aid this mentoring. (4) Mentoring program: The mentoring program will train,
educate and develop both mentors and mentees, using formative assessment with Six Sigma and 360°
evaluation approaches for iterative improvement. (5) Technological advancements: It is anticipated that this
COBRE with its engineering focus and device fabrication, should be able to push boundaries in
musculoskeletal devices, especially with our technology transfer connection (CUBEInC). (6) Evaluation Plan:
All components of the SC-TRIMH COBRE will use Six Sigma and 360° Evaluation approaches to improve
every aspect. (7) Interface between clinicians and engineers: The interface between disciplines is the best
place for innovations, thus facilitating interactions between diverse expertise, training, and scientific disciplines
which has the greatest potential for biomedical advances.

Public health relevance
NARRATIVE The mission of this Administrative (ADMIN) core is to successfully implement the COBRE for South Carolina Translational Research Improving Musculoskeletal Health (SC-TRIMH). The goal of SC-TRIMH is to develop a center with scientific cores and junior faculty all focused on improving muscle, bone, and joint health by using Virtual Human Trials (VHT). This will be put into practice by the Executive Committee which will be aided by an External Advisory Committee, an Internal Advisory Committee, and a Clinical Advisory Committee.